Endogenous stem cells promote regeneration of muscle in rotator cuff repair

Rotator cuff (RC) tears are the most common upper extremity injury, with over two million Americans
seeking medical attention annually. With the increased age of our veterans' population, RC tears are
becoming a vital health issue for the VA patients. Secondary muscle degradation following tears,
including atrophy and fatty infiltration (FI) are critical factors that directly determine the clinical
outcome of patients with this injury. Muscle residential fibro/adipogenic progenitor (FAP) cells have
been found to be the major cellular source of fat in RC muscle after massive tendon tears. We recently
discovered that these cells represent a heterogeneous cell population capable of both regenerative and
pathologic responses to muscle injury. Importantly, FAPs can differentiate into a beige adipose tissue
(BAT) phenotype that may have a role in promoting muscle recovery and regeneration in chronic injury
states. However, at this time, no studies have evaluated factors that influence the fate of FAPs in
human cuff tears, nor what FAP regenerative capabilities could be in clinical scenarios such as rotator
cuff repair. Clinically, both patient age and size of the rotator cuff tear have been found to be
independent factors that associate with poorer muscle quality and worse patient outcomes. However,
the interplay between patient and rotator cuff tear size and their influence on muscle stem cell
proliferation, differentiation, and regenerative capabilities is not known at this time. To address this
problem, we will perform the first large-scale clinical study evaluating FAP phenotypic properties in
patients with rotator cuff tears. Expanding on our promising mouse studies that show FAPs are capable
of stimulating muscle regeneration, we will perform a rigorous set of studies that will determine the
regenerative capabilities of human FAPs in this clinically relevant scenario to confirm our hypothesis
that the ability of FAPs to promote healthy muscle regeneration is dependent on the size of the tear and
age of the patient due to changes in FAP gene expression. By the end of this study, we will understand
how clinically important factors (age, tear size) affect the degeneration and regeneration potential of
human FAPs, which should provide critical information on how these endogenous stem cells can be
leveraged to improve precision guided patient outcomes with targeted therapeutic strategies in the near
future.

Public health relevance
Rotator cuff tears are increasingly common in the aging population. Patients with a nonfunctional rotator cuff are difficult to elevate the arm to perform activities of daily living. With the aging of our veteran population, rotator cuff tears are becoming a more and more important health issue for the VA patients. The development of muscle fibrosis and fatty infiltration (FI) are critical factors that determine the clinical outcome of patients with this injury. However, there is no effective treatment for this disease at this time due to our limited understanding of the mechanisms. Successful achievement of this project will define how clinically relevant factors such as aging and tear size affect stem cell changes within the muscle. Results from this study may lead to new therapeutic approaches to treat this disease. Therefore, our proposal has particular significance for the VA population.